NIMH MEG Core Facility

The MEG Core staff works interactively with a large group of PIs in NIMH, NINDS, and NIDCD, and NICHD for study design, task development, acquisition protocols, signal processing and data analysis. Procedures for data security, transfer and storage have been improved by moving the main data archive to the Helix maintained NIMH data store. Work with the Scientific and Statistical Computing Core to enable transfer of CTF MEG files to AFNI and developed tools for group statistical analysis was previously extended to include an extra-dimensional format to facilitate time-based connectivity across subject groups. This has been expanded to allow time-dimension comparison across subjects and groups. The comparisons can now be analyzed using anatomic atlas based alignment across subject. Signal analysis development has continued on event-related SAM (synthetic aperture magnetometry) and 275-channel ICA (independent component analysis). Development of time-frequency analysis methods has includedincludes Stockwell and wavelet transforms as well as multi-taper techniques. The analysis packages extended to include symbolic entropy measures and transfer entropy mutual information techniques to explore brain networks are in use by a number of user groups and are now being applied to eCOG data (these are direct cortical recordings). The ability to use SAM beamformer methods to analyze MEG signals during and after tACS (transcranial alternating current stimulation) as well as tDCS (transcranial direct current stimulation) has allowed exploration of effects on brain rhythms and memory and several studies are now underway by Dr. Cohen's group. An early test version of the upgraded package that will replace the external electronics has beenwas tested and performed properly across all channels.last year and the final version is now scheduled for installation Full installation is planned for fall 20176. The new eye-movement monitoring system previously installed and tested continues to contribute to cognitive activation paradigms. System reliability has been substantially improved after power system repairs. Several users are interested in pursuing studies with carefully controlled color visual stimuli. A new high quality visual stimulation system is being installed. Early work by Cornwell and colleagues demonstrated that MEG can reliably discriminate amygdala and hippocampal signals using MEG beamforming techniques. Continuing studies have shown that hippocampal function is impaired in patients with major depression as well as other brain changes when treated with ketamine. Further studies have shown that fast gamma activity in the hippocampus correlates with spatial learning. These studies are of particular interest to possibly elucidate the mechanism of the anti-depressant action of ketamine infusion. Previous results have shown that both increased anterior cingulate activity and functional connectivity during a working memory task can predict the antidepressant response of ketamine. Zarate and colleagues have utilized MEG to show that synaptic potentiation is critical for the antidepressant action in treatment resistant major depression. Previously Nugent et al. have shown group differences in MEG resting data that highlight dysfunction in major depressive disorder. This has now been extended to explore the network changes with ketamine administration. SDr Nugent has continued this work and has developed new analysis methods (multiband ICA) that high light the brain network changes across treatment and clinical groups.tudies continue to explore high gamma band activity across task and patient groups. Interaction with specific sodium channel genes finds that the cognitive differences may be related to gamma band activity. Studying how the brain organizes itself into functional networks is key to understanding normal human cognition as well as when it becomes disordered in mental illness. Previously, Bassett and co-workers using the spatial and temporal ability of MEG found that functional networks were characterized by small-world properties indicating a mix of both local connections and long range connections. We have also found differences in resting network patterns in patient groups, and have now used graph theoretical methods to examine functional networks. Functional connectivity metrics have been studied in an audio-visual task demonstrating that the communication across brain regions takes on several forms and that no one measure will suffice to capture the richness of information flow. New work by Grillon and Balderston has shown connectivity changes during anxiety manipulation. The proposed project to relate MEG dynamics to a new Diffusion Tensor Imaging (DTI) measure for determining latency across brain regions developed by Peter Basser's group was funded and protocol planning is underway. With Drs. Coppola and Nugent as co-chairs a two-day MEG Workshop was organized to bring together the North American MEG research community. Attendance was very strong and the community felt that such a meeting was long overdue. Several panels addressed the value-added aspect of MEG neuroscience research and how a supportive infrastructure can be advanced. A follow-on meeting will be held to build collaboration and synergy across laboratories.